Processive Antitermination of Antibiotic Synthesis Genes

Abstract
NusG is a transcription elongation protein used by virtually all organisms from the three domains of life. Bacterial
NusG associates with RNA polymerase (RNAP) through its N-terminal domain, whilst, despite its small size, the
C-terminal domain (CTD) forms dynamical interactions with other transcription factors (Rho, S10, NusB and
NusA) to affect transcription elongation. While all bacteria encode for a core NusG, many also synthesize
paralogs that transiently bind RNAP to alter expression of targeted genes. Yet, despite the importance of the
genes they regulate, most of the known subfamilies of NusG paralogs have not been investigated in depth (e.g.,
UpxY, TaA, and ActX). We recently discovered a new and widespread subfamily of NusG-like proteins, which
we called LoaP. Our preliminary investigation of this unique protein showed that Bacillus velezensis LoaP
activates expression of a regulon that is comprised of two different antibiotic synthesis operons. Upon further
inspection, we found evidence that suggests a broad regulatory relationship between LoaP and antibiotic
synthesis operons. This discovery is particularly important because our data suggests that the LoaP regulatory
protein reconfigures the transcription elongation machinery into an antitermination complex, capable of
bypassing multiple termination sites spread throughout the antibiotic synthesis operons. The presence of these
termination sites suggests that these operons have become ‘addicted’ to the LoaP antitermination factor, as their
transcription would be impossible without the dedicated antitermination complex. We speculate that this
observation explains why some antibiotic synthesis operons do not express well within the confines of a
heterologous host; they may have simply accrued termination sites that strikingly inhibit transcription elongation
in the absence of their cognate antitermination factor. Together, these data demonstrate how there is an urgent
need to better understand the genetic regulatory mechanisms affecting antibiotic synthesis operons, as this
information will influence the strategies used for discovering novel antibiotics and will lead to new tools for
improving heterologous production of antibiotics. Therefore, it is of significant importance to understand how the
LoaP antitermination mechanism exerts its regulatory influence over these important specialized metabolite
operons. Moreover, our preliminary data have demonstrated that LoaP uses a regulatory mechanism that is
different than those utilized by the other known NusG paralogs. In this project we will discover the molecular
mechanism used by LoaP to specifically manipulate transcription elongation of antibiotic synthesis operons. This
will significantly expand knowledge of the regulatory mechanisms that control antibiotic synthesis while also
revealing new and fundamental insight into the workings of the transcription elongation complex.

Public health relevance
Narrative There is an urgent need to better understand the genetic regulatory mechanisms that affect antibiotic synthesis operons, as this information will influence the strategies used for discovering novel antibiotics and will lead to new tools for improving heterologous production of antibiotics. We recently discovered a new family of transcription elongation factors called LoaP, which we hypothesize are broadly used for regulation of antibiotic synthesis operons. In this project, we will reveal the genetic regulatory strategy used by this important protein and show how its molecular mechanism provides unique and fundamental insight into the workings of the transcription elongation complex.